The early life exposome, emerging chemical exposures, and structural and functional brain development in childhood

PROJECT SUMMARY/ABSTRACT
Rapid brain growth and development throughout the first years of life and the fragility of the blood brain barrier
cerebrovasculature render the early childhood brain (birth-age five) uniquely susceptible to chemical exposures.
Children are exposed to pesticides, flame retardants, and other suspected and known neurotoxicants in air,
water, and dietary sources through exposure opportunities that are either uniquely high in early life (e.g., fruit
and vegetable consumption, air intake) or specific to this developmental window (e.g., breastfeeding, hand to
mouth behaviors, crawling exposure to house dust, and sustained contact with baby products). Despite evidence
linking prenatal chemical exposures to neurodevelopmental deficits, insufficient biomonitoring in early childhood
limits our understanding of the early life chemical exposure landscape, and few studies have assessed changes
in underlying neural substrates. My objective is to characterize the early life chemical exposome and its impact
on structural and functional brain development during this critical period of brain growth. I propose to leverage
the University of North Carolina Baby Connectome Project (BCP), a longitudinal study that maps brain growth
and development in early life using serial structural and resting-state functional magnetic resonance imaging
(MRI), paired with developmental assessments and repeated child urine specimens to measure environmental
exposures. During the K99 phase, I will characterize longitudinal patterns in the untargeted early life urine
exposome and their associations with structural brain growth (among 250 children contributing 540 scan-urine
pairs between 0-5 years). During the R00 period, I will generate novel exposure data by launching a targeted
investigation measuring biomarker levels of high priority contaminants identified in the K99 period, as well as
emerging fungicides and organophosphate esters that have been prioritized for early life biomonitoring based
on toxicologic evidence of neurotoxicity and uncertain exposure burden. I will use innovative mixture methods to
estimate associations between these emerging exposure biomarkers, brain anthropometry, functional network
connectivity, and developmental assessments. The proposed work combines omics technology, longitudinal
neuroimaging, and innovative dimension reduction methods to establish mechanisms of chemical neurotoxicity.
To be successful in the proposed work and launch my independent research career, I need to gain: (1) statistical
skills for analyzing high dimensional exposomic data, (2) proficiency in interpreting neuroimaging data, and (3)
professional skills to establish and maintain an independent research program. The K99 structured training plan
and exceptional team of mentors and scientific advisors will help address each of these dimensions. This award
will provide a critical foundation for me to launch an independent research career investigating the impacts of
environmental exposures on child health and development. This study has significant public health impact
because it can causally link chemical exposures with adverse effects, leading to earlier interventions and
improved neurodevelopmental outcomes.

Public health relevance
PROJECT NARRATIVE Early life is a culmination of rapid brain growth and development, uniquely high chemical exposures, and heightened vulnerability to toxicants. Despite this, relationships between toxicant exposures and the developing brain are poorly understood. This study will characterize the early life chemical exposome and its impacts on biomarkers of brain growth and development before age five, ultimately informing efforts to reduce chemical exposures and improve childhood neurodevelopmental trajectories.